Training in Child/Adolescent Biobehavioral HIV Research

DESCRIPTION (provided by applicant): Well-trained researchers are needed in the next decade to address the challenge of HIV/AIDS especially among children and adolescents. Effective programs are needed for both the prevention of HIV, as well as intervention for those infected by HIV. This research training program is directed at Ph.D. and M.D. fellows to prepare them to carry out independent research. The Bradley/Hasbro Children's Research Center has faculty with expertise in HIV prevention, other risk behaviors, normative development, psychopathology, and the psychology of physically ill youth. Additional faculty at Brown (through the Center for AIDS Research) have expertise in the medical care of HIV infected youth and adults, HIV testing, Treatment as Prevention, STIs, substance abuse, and international health. The strong faculty record of NIH funded research ensures that trainees are exposed to thriving areas of programmatic research. Trainees benefit from the accumulated and diverse expertise by having two mentors, each with a different focus. Mentors focus on either 1) child/adolescent behavioral health, developmental or mental health issues or 2) medical aspects of HIV research. Training involves interdisciplinary and translational elements to prepare trainees for the integration of the medical, psychiatric, and developmental issues and as it informs Biobehavioral HIV/AIDS Research. The program has a total of five postdoctoral trainees and two summer trainees each year. Two new psychology trainees are enrolled every year for a two-year fellowship(with an optional third year) and one new M.D. will be enrolled in alternate training years. Consistent with each trainee's individual needs, a graduated program for progressive independent research is designed. A formal training curriculum targets specific learning objectives aimed at skills needed for the next generation of HIV research. Core areas of learning include models of behavior and its change, behavioral assessment, mental health issues, biology and medical treatment of HIV, and medical aspects of prevention. Curriculum needs can be satisfied by HIV-specific seminars, general research design seminars, and by tutorial in addition to formal courses at Brown or nearby universities.

Public health relevance
PUBLIC HEALTH RELEVANCE: Well-trained researchers are needed in the next decade to address the challenge of HIV/AIDS especially among children and adolescents. This research training program is directed at Ph.D. and M.D. fellows to prepare them to carry out independent research. Faculty from the Bradley/Hasbro Children's Research Center and at Brown (through the Center for AIDS Research) provide mentoring and didactic instruction on 1) child/adolescent behavioral health, developmental or mental health issues and 2) medical aspects of HIV research. Training involves interdisciplinary and translational elements to prepare trainees for the integration of the medical, psychiatric, and developmental issues and as it informs Biobehavioral HIV/AIDS Research.